The intersection of diet, cell metabolic state, and SIV reservoir transcription

Project Summary/Abstract
The main obstacle to curing HIV-1 infection is a reservoir that consists of resting memory CD4 T cells whose genomes
contain inducible and replication-competent HIV-1 proviruses. Decay of the reservoir is slow and this has reinforced a
notion that proviral HIV-1 DNA is largely transcriptionally silent. A wide body of recent evidence has pointed to the
contrary. At any point in time, a non-negligible fraction of the HIV-1 reservoir remains transcriptionally active despite
complete suppression with antiretroviral therapy (ART). Moreover, latent HIV-1 transcription can be induced above these
apparent baseline levels with HIV-1 stimulatory compounds, deemed latency reversal agents (LRAs). Some LRAs have
been able to modestly reduce reservoir size in small clinical or pre-clinical trials of HIV-1+ humans or SIV+ rhesus
macaques (RMs). However, a current limitation of LRA use is that to date, these agents have been tested only in very
narrow patient/animal cohorts, not representative of heterogeneity that exists in the HIV-1+ population, and not accounting
for age, gender, or the prevalence of additional co-morbidities associated with HIV-1. Type 2 diabetes in particular is a co-
morbidity that is prevalent in PLWH, and is the result of an imbalance of the dietary hormone insulin. In preliminary
studies, we find that CD4 T cells (which serve as the principle reservoir for HIV-1) express the insulin receptor and respond
to insulin by activating the PI3K signaling pathway. PI3K signaling is known to be upstream of (1) metabolic regulators of
latent HIV-1 transcription (mTORC signaling) and (2) transcription factors involved in binding to the HIV-1 promoter (Sp1
and FOXO1). In these proposed studies, we will take advantage of an existing well-powered cohort of fully ART-suppressed
SIV+ RMs to probe the role of insulin signaling as a regulator of the HIV-1/SIV lifecycle. We will employ cutting-edge
phospho-proteomic methods to examine how the dietary hormone insulin influences transcription of latent SIV in (Aim 1)
the context of LRA-based biologics that share common signaling cascades with insulin and (Aim 2) the context of natural
blood glucose/insulin fluctuations that occur with dietary intake. The application will seek to define on a basic level (1) the
insulin “signalome” in CD4 T cells (2) as-yet explored dietary factors that may influence transcriptional activity of latent
HIV-1 and importantly (3) provide a conceptual framework for future studies on LRA use in settings in which insulin
signaling is impaired.

Public health relevance
Project Narrative Reversal of latent HIV-1 to its transcriptionally active form represents possibly the only way in which a latent HIV-1 infected cell can be identified. Our proposed studies aim to examine the role of a dietary hormone, insulin, on promoting latent HIV-1 transcription. In the long-term, the proposed studies will hope to provide a rationale for studying current and future HIV-1 cure therapies in persons living with HIV-1 who also have Type 2 Diabetes.